VARICELLA SEROLOGIC STATUS OF HOSPITAL PERSONNEL

The purpose of this study is to determine seroprevalence of Varicella (chicken-pox) antibody among a representative sample of Cedars-Sinai Medical Center personnel. The data obtained from this study will be given to the CDC. They will use this when making a recommendation for the vaccination of adults.